Glucose Management Clinical Decision Support to Improve Outcomes in Academic and Community Hospitals

Project Summary/Abstract
Approximately 9 million patients with diabetes (DM) are hospitalized annually and over 30% of inpatients without
DM experience high glucose (HG) due to their acute illness. HG increases the risk of infectious and non-
infectious complications and death, hospital length of stay (LOS), utilization of hospital resources and overall
healthcare costs. While glucose control reduces these risks, controlling HG in the hospital is difficult due to
multiple barriers such as recognizing and proactively treating glucose abnormalities, and adequately ordering
insulin to treat HG in the hospital. Clinical decision support (CDS) is a system that uses computerized person-
specific data in the electronic medical record (EMR) proven to improve hospital care. Among the various
modalities, alert-CDS is shown to improve care delivery, providers’ proactivity, and glucose control specifically
in intensive care settings of academic institutions. However, alert-CDS has not yet been studied outside of
intensive care units (ICU), or in community hospitals where most patients receive care. Furthermore, its impact
on patients’ outcomes has not been tested in any setting. The proposed project uses an innovative alert-CDS
tool we developed and validated which automatically identifies dysglycemia and inadequacies in insulin
administration in the hospital. It alerts clinicians with recommendations to support decision making without
superseding their clinical judgement. In our pilot study, we found that this alert-CDS tool reduced recurrent high
glucose levels and shortened LOS. Based on this promising preliminary data, in this project we propose to study
the impact of our CDS tool on clinical, economic and providers’ performance outcomes among non-intensive
care patients both in an academic and a community hospital. We propose to make this resource available
intermittently in the EMR every 3 months during 36 months, thus allowing us to compare 18 months of
intervention and 18 months of standard care. Based on our pilot study, we expect that a sample size of 12,560
subjects will give us an 80% power of detecting 0.34 days (~ 8 hours) difference in length of stay, the primary
endpoint of our study. We propose the following aims: Aim 1) To determine the impact of the alert-CDS over
conventional care on the clinical outcomes of non-ICU patients in an academic and a community hospital. Aim
2) To determine the impact of the alert-CDS over conventional care on the economic outcomes of non-ICU
patients in an academic and a community hospital. Aim 3) To determine the impact of alert-CDS for inpatient
glycemic control on providers’ perspectives, competencies and practice performance between an academic and
a community hospital. We hypothesize that the tool will increase providers’ knowledge about dysglycemia
allowing them to make better decisions about insulin administration. The anticipated success of our study builds
upon a well-established multidisciplinary team of investigators strongly supported by leadership stakeholders in
both hospitals. Our proposed study has the potential of establishing a new paradigm in the management of
dysglycemia in hospitalized patients with a major positive impact on clinical and economic outcomes.

Public health relevance
Project Narrative This research will compare the effectiveness of alert-clinical decision support (CDS) for the management of abnormal glucose in the hospital on clinical, economic and practice performance outcomes in patients admitted to an academic and a community hospital. Anticipating an impactful project, this tool will optimize hospital glucose control and improve patients’ outcomes providing an evidence-based resource to improve patient care. As a subsequent advancement of this alert-CDS, it can be adapted into an electronic medical agnostic tool using standards of interoperability within health informatics to widely benefit many patient across hospitals.